Imaging and Cell Culture Core

Core C, The Imaging and Cell Culture Core, incorporates a change in the Core's focus from the current funding period. Currently, Core C serves as the Adenovirus and Cell Culture Core. While it retains those responsibilities, it now incorporates the imaging capabilities that were previously within Core B. Core C will be an integrated resource for comprehensive evaluation of murine phenotypes encompassing gross, microscopic and ultrastructural abnormalities ofthe mouse models prepared and studied by the 3 Projects. In this manner, developing pathology, as visualized at the light and electron microscope levels, can be correlated to overall organ function (Core B). Core C will continue to provide primary cell cultures to the investigators on a weekly basis, if needed, with neonatal rat or mouse fibroblasts and cardiomyocytes being isolated for experiments. The Core will also continue to service the adenovirus needs of the Projects. Imaging needs will be central to analyses ofthe animal models and will incorporate light microscopy, electron microscopy, immunohistochemistry and traditional histopathology. Cell culture needs will continue to be serviced by the Core, as the Projects will require the preparation of both fibroblasts and cardiomyocytes as well. Additionally, during the present funding period, the Core has developed the capabilities of routinely isolating these cells ifrom adult mice, which will be needed by the Projects in this renewal. The Core's Director is an accomplished, very experienced light and electron microscopist, who has focused her entire professional career on the structural analyses of striated muscle. She will be aided by James Gulick, a Research Instructor! who is expert in cell culture, molecular biology and adenoviral preparation and maintenance. All Projects will use this Core. RELEVANCE (See instructions); Visualization of the changes that occur in the heart tissue and in cardiac cells is very important in understanding the consequences ofthe studies being carried out. This Core will provide those capabilities.